UTAH IAIMS DEVELOPMENT PROJECT

Long Term Objectives: To test the concept of an Integrated Academic Information Management for the Health Sciences Center at the University of Utah. Specific Aims: 1. To develop and implement five pilot projects creating knowledge bases to support medical decision making in teaching, research, and clinical environments. Experts will use clinical data from hosptal information system & ILS to create knowledge bases. 2. To install an Integrated Library System and to develop an interface between the ILS and the hospital decision support system which will validate decisions using current literature.